Targeting macrophage maladaptation for bacterial sepsis treatment

Summary. Sepsis results in massive loss of life and places a significant economic burden on society. There
are no effective treatments available for human sepsis other than antibiotics and life support. It is increasingly
clear that sepsis is a bi-phasic process comprised of 1) an early high-energy demanding hyperinflammation
state that can cause inflammatory shock and 2) a low energy supply immunosuppression state that promotes
immunometabolic paralysis while countering oxidative damage. These two phases are seamlessly connected
or even concurrent. This makes sepsis treatment extremely difficult, and many therapies such as anti-
inflammatory corticosteroids often worsen the outcome. Macrophages (MΦs) play essential roles throughout
the course of sepsis. In the hyperinflammation phase, MΦs sense pathogen-associated molecular patterns
(PAMPs) through receptors such as toll-like receptors (TLRs) and NOD-, LRP-, and pyrin domain-containing
protein 3 (NLRP3). MΦ NLRP3 inflammasome activation and resulting IL-1β secretion cause acute organ
damage and release of damage-associate molecular patterns (DAMPs), which act back on the inflammatory
pathways, forming a vicious cycle. Therefore, the MΦ NLRP3 inflammasome is a major contributor to the
hyperinflammation phase of bacterial sepsis. Concomitant with inflammasome activation, MΦs undergo a
broad cellular metabolic rewiring that favors glycolysis and turns mitochondria from ATP generation to reactive
oxygen species (ROS) production, leading to mitochondrial oxidative stress, metabolic paralysis, and MΦ
anergy in the immunosuppression phase. In addition, NLRP3 inflammasome activation results in GSDMD-
mediated pyroptotic cell death (pyroptosis), directly removing MΦs from the fight against secondary infections.
Recently, we identified that in MΦs, pyruvate dehydrogenase kinase 1 (PDHK1) plays a critical role in
coordinating inflammasome activation and metabolic rewiring. In MΦs treated with LPS and ATP or Nigericin to
stimulate inflammasome activation, dichloroacetate (DCA, a pyruvate analog and pan-PDHK inhibitor) or JX06
(a synthetic small-molecule and selective PDHK1 inhibitor) effectively suppressed IL-1β secretion and cell
death, improved mitochondrial integrity, and reprogramed mitochondria from ROS production to ATP
generation. In a mouse cecal ligation and puncture (CLP) model, PDHK inhibition significantly reduced plasma
IL-1β levels. In this STTR Phase 1 project, we will test the hypothesis that JX06 can be developed as a novel
therapy for bacterial sepsis. We propose two specific aims: SA1. To determine the toxicity of JX06 in cultured
primary mouse and human cells in vitro and mice in vivo, and to study its pharmacokinetics in mice. SA2. To
establish the effectiveness of JX06 in various mouse strains using the CLP model of sepsis. This STTR Phase
1 project will validate the role of MΦ PDHK1 in bacterial sepsis and provide a proof of concept to develop JX06
or its analog as a new therapeutic agent for bacterial sepsis. The successful completion of these proposed
studies will serve as a milestone for the further development effort.

Public health relevance
Narrative. Sepsis results in massive loss of life and places a significant economic burden on society. There are no effective treatments available for bacterial sepsis. We propose to develop JX06, a selective macrophage PDHK1 inhibitor, as a novel therapy for bacterial sepsis by suppressing macrophage NLRP3 inflammasome activation and restoring macrophage metabolic health.